UCCC P30 Supplement: Human Endogenous Retrovirus-H as a Target for Early-Onset Colorectal Cancer

Abstract
Early-onset colorectal cancer (EOCRC), defined as diagnosis before age 50, has shown a significant rise in
incidence, contrasting with declining rates in late-onset CRC. EOCRC tumors frequently exhibit microsatellite
stability and harbor TP53 mutations. Despite extensive RNA sequencing efforts in colorectal cancer (CRC), the
expression of retroelements (REs), particularly human endogenous retroviruses (HERVs), in CRC remains
largely underexplored. Members of the HERV-H family can be reactivated in CRC and may contribute to an
immunosuppressive tumor microenvironment (TME). However, it is not currently known if TP53 mutations, found
at higher incidence in EOCRC, contribute to increased HERV-H expression which drives tumor metastasis and
immune evasion. We propose that the increased expression of specific HERV-H loci in patients with TP53-
mutated EOCRC enhances tumor growth and suppresses the immune response, and that anti-retroviral therapy
will decrease HERV-H expression, resulting in improved immune control of the tumor. This project aims to identify
and characterize HERV-H loci with increased expression in TP53-mutant EOCRC and evaluate their impact on
the TME and tumor progression. Long-read RNA sequencing will be used to detect full-length RE transcripts in
patient-derived xenograft (PDX) models from EOCRC and late-onset CRC cases expressing wild-type or mutant
TP53. Spatial transcriptomics and multiplexed immunofluorescence will localize RE expression within tumor
tissues and define associated immune phenotypes using a panel of 20 immune markers. Differential expression
analysis will prioritize candidate loci based on enrichment in TP53-mutant EOCRC (compared to late onset and
wild-type P53 CRC) and tumor-specific or immune cell expression. Functional validation will include RNA in situ
hybridization and quantitative PCR in tumor and immune cell populations. The influence of RE expression on
immune cell infiltration, activation, and phenotype will be assessed, with particular focus on B cells, T cells, and
innate immune components. Therapeutic modulation of RE expression will be tested using an FDA-approved
antiretroviral therapy (3TC) with tumor growth and RE transcript levels as primary endpoints. Integration of
transcriptomic and spatial data will provide a comprehensive view of RE-driven immunomodulation in EOCRC.
The proposed research seeks to establish a mechanistic link between TP53 mutations, HERV-H expression,
and EOCRC progression. Findings may inform the development of diagnostic markers and targeted therapies,
including repurposed antiretroviral agents, for personalized treatment of EOCRC patients.

Public health relevance
Project Narrative Since the 1990s, the frequency of early-onset colorectal cancer diagnosis (EOCRC, in people 18-49-years-old) has increased at an alarming rate relative to late-onset colorectal cancer (over 50-years-old) which has been decreasing. Although repetitive DNA sequences, originating from germline incorporation of ancient retroviruses, are increasingly expressed in tumors, it is unknown what drives increased expression of specific repetitive sequences. The studies proposed herein are to identify which repetitive DNA sequences are expressed in EOCRC, what drives their expression, and determine if antiretroviral therapies will limit expression of these sequences and, importantly, tumor growth.